MUSC Specialized Center of Research Excellence on Sex Differences--BIRCWH Scholars Innovation Program

Contact PD/PI: McRae-Clark, Aimee L.
ABSTRACT
The MUSC Specialized Center of Research (SCOR) on sex/gender differences in addictive disorders and the
relationship between stress and relapse has been highly productive for 15 years. In addition to coalescing a
multidisciplinary group of investigators across different disciplines working closely together to explore sex and
gender differences in addictions and the relationship between stress and drug use, the MUSC SCOR has
provided a fertile training ground for new investigators and attracted senior investigators to apply their skills to
sex- and gender-specific research. During the proposed renewal period, we will transition to a Specialized Center
of Research Excellence (SCORE). We will continue to reach across campus and also extend our reach to
nationwide, cross-SCORE collaborations and community-based initiatives focused on dissemination of research
findings to improve health outcomes. The science within our research group also will grow with three tightly
integrated research projects, new investigators and innovative technologies. To address critical public health
needs, the proposed research projects will investigate sex differences in cannabis and opioid use disorders and
directly inform addiction treatment development. The specific aims of this SCORE are to support and enhance
translational scientific collaborations among the investigators conducting primary and pilot research projects,
catalyze further growth of interdisciplinary sex- and gender-based research on the MUSC campus, expand
foundational research training for Early Career Investigators dedicated to sex and gender-focused translational
research, and develop strategic partnerships to enhance the translation and dissemination of SCORE findings
and other relevant research to improve health outcomes.
Page 84
Project Summary/Abstract

Public health relevance
PROJECT NARRATIVE The proposal describes a training program, led by sex and gender researchers at the Medical University of South Carolina, which will provide supplemental training for BIRWCH scholars nationwide in the area of women’s health and substance use disorders. This multi-modal training program will include online and in person didactics, consultation and mentorship as well as pre-review of grants before submission. This program will diversify and expand the scientific workforce in the critically important area of women’s health and SUDs and improve success in obtaining grant funding for participants.